Minnesota Chat: Public Perspectives On Health Insurance

This protocol was designed to determine how residents of Minnesota would choose to define their health insurance benefit package. The results are intended to inform the managed care industry in Minnesota to attend to rising costs and dissatisfaction with choices in health care. The study instrument has been designed. The study design has been completed. Participant recruitment and participation has been completed. Data processing and data analysis are complete.